Elucidating the role of Ybx1 in cerebellar development and medulloblastoma

Project Summary
The cerebellum is part of the mammalian hindbrain which plays important roles in motor control and some
cognitive functions, such as language and spatial memory. Although these functions are complex, the continued
development after birth and simple structure of the cerebellum make it unique model for understanding
postnatal regulation of gene expression, proliferation, and differentiation. Interestingly, the same signaling
pathways that play a role in normal cerebellar development are commonly hijacked and altered in cancers, such
as medulloblastoma (MB) – the most common malignant pediatric brain tumor. MB is divided into four
subgroups, where mutations in these signaling pathways are known to occur in the SHH and WNT subgroups,
with very few recurrent alterations in Group3 and 4 tumors. Recent studies, however, have identified a number
of overexpressed developmentally regulated genes that are attractive therapeutic targets. Y-box binding protein
1, YBX1, recently identified to control proliferation/differentiation in the developing embryonic brain, is highly
expressed in the cerebellum during both proliferative and differentiation phases. Further, YBX1 levels are high
in all subgroups of medulloblastoma with the highest expression seen in high-MYC expressing MBs (Group3-
G3). Therefore, understanding the functional role of YBX1 in both cerebellar development and in
medulloblastoma is highly relevant. Our preliminary studies show that YBX1 is required for proper specification
of the cerebellum and that loss of Ybx1 diminishes the growth of G3 MB in vivo. The three aims of this proposal
are to: 1) determine the role and function of YBX1 in regulating proliferation/differentiation of cerebellar
progenitors, 2) assess the requirement of YBX1 in initiation and progression of medulloblastoma using both
human and mouse models, and 3) identify target genes and epigenetic alterations downstream of YBX1. Finally,
I will assess if direct antagonism of YBX1 can inhibit tumor growth. This study will uncover new gene regulatory
networks of cerebellar development as well as those which regulate MB initiation and progression, leading to
the identification of novel targets. The integration of neurodevelopment, stem cell biology, biochemistry, and
cancer biology make this an innovative research proposal that will be significant for increasing knowledge about
the normal functions of YBX1 as well as solidifying it as a pharmacological target in G3 MB. This proposal builds
upon my strong background in epigenetics, stem cell biology, and cancer biology from both my pre- and post-
doctoral fellowships. My short-term career goal is to obtain a research faculty position at a leading institution
where I will focus on understanding epigenetic mechanisms in normal development and tumorigenesis. With
assistance from core facilities here at St. Jude and my future institution as well as collaborations both old and
new, this award will allow for further training in CRISPR/Cas9 gene editing and bioinformatics analysis.
Completion of this proposal will put me in a perfect position to continue work towards my long-term goal of
fulfilling the NCI mission “to advance scientific knowledge and help all people live healthier, longer lives.”

Public health relevance
Project Narrative The cerebellum coordinates a number of processes including balance control, speech and spatial memory; abnormal development of the cerebellum is associated with a number of neurological diseases including medulloblastoma (MB), the most common malignant brain tumors in children. This proposal utilizes a number of state-of-the-art tools and techniques to investigate the role of YBX1 in regulating stem cell self- renewal and differentiation in the cerebellum and in MB using both mouse and human models. Results from these studies will lead to insights in epigenetic regulation of cerebellar development and the development of MB and further our understanding of the molecular mechanisms underlying YBX1 function which might lead to the design of novel therapeutic approaches for the treatment of MB.